Epidemiologic research on screening for vestibular and balance disorders: supplement for people with Alzheimer's disease

Relationship to Alzheimer's disease and its related dementias This application is a response to NOT-AG-18-039 . This pilot study, using 60 subjects from one clinic, will be the first to test Alzheimer's disease (AD) patients directly on a thorough battery of standard, objective diagnostic tests of the vestibular system (ENG). Subjects will be patients with mild to moderate AD. We will estimate the prevalence of vestibular disorders in AD and compare their performance to that of healthy controls in the parent study who will have been tested on the same test battery. Therefore, we will be able to determine if the prevalence differs from age-matched controls. We will use clinical data to determine if severity of cognitive impairment or reduced hippocampal volume on MRI are related to increased prevalence of vestibular impairment.

Public health relevance
Narrative We will test people who have Alzheimer's disease (AD to will determine if they have a greater prevalence of vestibular (i.e. inner ear) disorders causing dizziness and balance problems than in the general population. We will also determine if these differences are related to changes in cognition or volume of an important brain structure known to be compromised in AD, the hippocampus. If AD patients have more vestibular disorders than healthy controls, and/ or if the hippocampus is involved, then better methods for diagnosis and treatment can be developed to help them.